HUMAN RELAXIN FOR PATIENTS WITH SYSTEMIC SCLEROSIS WITH DIFFUSE SCLERODERMA

Relaxin a 6000 MW protein is normally secreted by corpus luteum and placenta throughout pregnancy. It's biologic effects include remodeling of connective tissue. Recombinant relaxin is of theoretical benefit in scleroderma, a disease characterized by thickening and fibrosis of the skin and distinctive fibrosis of internal organs, including the lungs, kidneys and gastrointestinal tract. Currently there is no known therapy for scleroderma. A phase I trial of continuous subcutaneous relaxin in 30 patients with scleroderma showed no serious adverse effects or clinically significant drug-related laboratory abnormalities. This study will be randomized, double blind, phase II trial of safety and efficacy of subcutaneous continuous infusion of recombinant, human relaxin for 24 weeks at two different dose levels, versus placebo in patients with diffuse scleroderma. Safety evaluation will include vital signs, urinalyses, hematology, chemistry and coagulation profiles, and recording of adverse events.